Southwest Hub for American Indian Youth Suicide Prevention Research

The Administrative Core of the Southwest Hub for American Indian Youth Suicide Prevention Research
(Southwest Hub) will function as the backbone of the research and administration initiatives of the
youth suicide prevention enterprise. It will provide essential management, logistical and technical
support to successfully implement the proposed study, capacity building activities, and application of
findings to policy development and practice to prevent American Indian youth suicide and promote
resilience among Hub partners and beyond. Hun team members include technical lead, johns Hopkins
Center for American Indian Health (CAIH); core research intensive partners, the White Mountain
Apache Tribe and Navajo Nation; and satellite partners, the San Carlos Apache, Hualapai and Cherokee
Nations. Primary aims of the Administrative Core are: 1) oversee the responsible and accountable
administration, coordination and fiscal management of all activities of this NIMH U19 cooperative
agreement; 2) optimize effective, unified, timely and transparent communication, collaboration,
interaction, and decision-making among the multi-disciplinary research team, tribal community
collaborators; allied health service and policy organizations; other Hub grantees and their networks; and
NIMH staff; and 3) conduct outreach and dissemination activities in consultation with tribal leaders to
ensure key findings reach most relevant audiences to inform mental health programs, practices and
policies to promote AIAN youth health and well-being. CAIH is well-situated to administer the Southwest
Hub with current reach to indigenous populations across North American, substantial experience
managing a portfolio of over 70 federal grants, and successful dissemination of its evidence-based
programs to over 75 tribal communities. Innovative aspects of our Administrative Core include:
leveraging well-formed Community Advisory Boards, paired teams of academic and community
partners for capacity development, and innovative technology for project management,
communication and collaboration. The Southwest Hub partners are poised to expand upon trusted
research relationships to produce novel evidence, and exercise tribal sovereignty and extensive
networks to overcome tribal youth suicide disparity, while contribution new understanding about
promoting youth resilience.